ClinTAD: A Tool for Improving Clinical CNV Interpretation

PROJECT SUMMARY/ABSTRACT
DNA microarray is a routine clinical pediatric diagnostic test to identify genomic copy number variants (CNVs)
that could be causative of autism, developmental delay, and multiple congenital anomalies. This test is also
used frequently in the prenatal setting to find genomic causes of fetal anomalies found by ultrasound, or to
predict potential phenotypes postnatally. Current clinical guidelines for interpretation of CNVs focus solely on
the characteristics of genes contained within the CNV breakpoints. However, recent studies on chromatin
architecture, utilizing Hi-C or related techniques, have demonstrated that CNVs can also disrupt the structure
of topologically associated domains (TADs). TADs are “neighborhoods” of physical DNA interactions that serve
several functions, including the prevention of ectopic gene-enhancer interactions. This TAD disruption can lead
to pathogenic alterations in transcription of genes outside the CNV region that are ultimately causative of
disease. The central hypothesis of this proposal is by only focusing on genes within the CNV region for clinical
interpretation, critical genomic information is being entirely ignored in DNA microarray interpretation, ultimately
leading to missed diagnoses for patients. To address this issue, we have recently developed the free-to-use
software ClinTAD (www.clintad.com; J Hum Genet (2019)) to assist in the interpretation of CNVs while taking
potential TAD disruption into account. To our knowledge, this is the first software of its kind to attempt to
integrate TADs into clinical CNV interpretation. While ClinTAD v1.0 is currently available as a decision support
tool to assist in clinical practice, it is currently limited both in its ease-of-use as well as its predictive power.
Further enhancing the utility of ClinTAD motivates the two Aims of our proposal here: 1) We aim to optimize
ClinTAD as both a clinical decision support and research tool by allowing incorporation of TAD boundaries
from different datasets, enabling an API for analysis of large case cohorts, adding interpretation tools for
Regions of Homozygosity found on SNP array, and allowing for creation of a de-identified database where
users can upload cases with suspicion for pathogenicity based on TAD disruption. 2) We aim to improve the
predictive power of ClinTAD through machine learning to identify the most predictive features of pathogenicity
in a large, publicly available CNV cohorts, as well as by incorporating a recently-described convolutional neural
network-based model which can predict TAD disruption as a function of CNV breakpoints. In this proposal we
aim to make ClinTAD the premier tool for the interpretation of CNVs in the context of TAD disruption. Our long-
term goal is to build a collaborative network of users that will enable us to identify patients with the most
probability of having clinical phenotypes caused by TAD disruption. Such a unique patient cohort could then
form the basis of a first-of-its kind trial to evaluate the utility of Hi-C as a clinical test.

Public health relevance
PROJECT NARRATIVE Children with conditions such as autism, developmental delay, and other abnormalities found at birth frequent have a medical test done called DNA microarray. While this test is certainly useful, we believe that this test is missing the correct diagnosis in some patients because of limitations in current guidelines for interpreting test data. Here we aim to further improve our free-to-use software tool, called ClinTAD, to help make these correct diagnoses in patients that are currently being missed.